mRNA Alternative Splicing Regulatory Networks in the Specification of Cortical Interneuron Subtypes

Project Summary/Abstract
Alternative splicing of pre-mRNAs is extensively employed by the nervous system to expand the transcriptomic
manifold. Regulated in specific cellular contexts by multiple RNA-binding proteins (RBPs), this process is a major
contributor to cellular identity that acts orthogonally to transcriptional regulation and has been implicated in many
neurodevelopmental disorders. Understanding and integrating the impact of alternative RNA splicing on the
establishment and organizational hierarchy of interneuron subtype specification is therefore of high value, though
there has been relatively little progress in this direction. To address this gap, we have designed a high throughput
system to determine the role of alternative splicing regulatory networks in cortical interneuron subtype
specification. We hypothesize that alternative splicing is an informative component of interneuron cell fate
decisions. Using scRNA-seq datasets with in-depth and full transcript read coverage across diverse neuronal
cell types, we will identify key RBPs by highly correlated expression with cell-type specific splicing patterns
together with integrative analysis of RBP target networks. We will then test the role of these RBPs by CRISPR
knockout in mESCs differentiated into interneuron subtypes using a dual interneuron lineage fluorescent reporter
line that we have developed. Training in splicing analysis in the expert environment of the Zhang lab is an ideal
complement to the trainee’s previous extensive training in interneuron biology. The proposed studies and training
plan will provide a fertile basis for a productive independent research program synthesizing traditional
neurodevelopment with state of the art bioinformatics. Alternative splicing and cellular diversity are known to be
closely intertwined and important in mature neurons; a better understanding of the inception of these
relationships will be greatly impactful to our understanding of the nervous system in health and
neurodevelopmental disease.

Public health relevance
Project Narrative: mRNA editing by RNA binding protein regulatory networks, increasingly associated with numerous neurodevelopmental disorders, greatly expand the complexity of the mammalian nervous system. These studies will employ state of the art bioinformatic analyses to identify protein-mRNA relationships important for generating neuronal cell types during development. These relationships will then be tested in a high-throughput in vitro system providing vital insight into the mechanisms underlying the hierarchical organization of cortical cell diversity.